The role of hepoxilin A3 in neutrophil breach of the Infected airway mucosa.

PROJECT SUMMARY / ABSTRACT
Mucosal epithelial surfaces are physical and immunological barriers that protect against external threats. A
hallmark of infectious inflammatory disease in the respiratory tract is massive accumulation of neutrophils into
the airspace. Infection triggers a process whereby neutrophils emigrate from circulation to the airspace where
they confront mucosal invaders, however, this can be excessive and contributes to tissue damage as observed
during pneumonia and cystic fibrosis. Neutrophil breach mucosal epithelial barriers to reach the airway and
the molecular mechanisms that control this process are being explored. Using mouse and human primary and
transformed polarized lung epithelial cells cultured on permeable Transwell filters, bacterial-induced neutrophil
trans-epithelial migration can be modeled as an in vitro co-culture. Treatment of lung epithelia with the
bacterial pathogen P. aeruginosa activates phospholipase A2, releasing arachidonic acid. Arachidonic acid is
converted by a lipoxygenase to hepoxilin A3 (HxA3). HxA3 is released at the apical surface of lung epithelial
monolayers guiding neutrophils across the epithelial barrier. Neutrophils that have migrated across the barrier
subsequently release leukotriene B4 (LTB4) through a distinct lipoxygenase activity. LTB4 substantially
augments the magnitude of this migratory process causing breach of the airway barrier by large numbers of
neutrophils. This proposal herein aims to build upon current understanding of mechanisms underlying HxA3
and LTB4 synthesis in epithelial cells and neutrophils respectively and how these events orchestrate neutrophil
trans-epithelial migration in response to P. aeruginosa. Knockout mice and molecular techniques to delete
phospholipase A2 and lipoxygenase genes in epithelial cells, neutrophils, and bacteria, will be used to pinpoint
dominant enzymes driving this process. Upstream signaling events that trigger eicosanoid generation through
phospholipases and lipoxygenases will also be addressed. A differentiated air-liquid interface culture system
derived from primary airway basal stem cells has been established and paired with advanced imaging to model
bacterial-induced neutrophil trans-epithelial migration and assess molecular and cellular mechanisms. Finally,
the hypothesis that HxA3 collaborates with LTB4 as key neutrophil chemotactic signals operative at airway
mucosa to drive neutrophil trans-epithelial migration in vivo will be critically evaluated by employing a mouse
model of P. aeruginosa-induced acute pneumonia. Neutrophil recruitment into mouse airspace will be
analyzed in the presence and absence of eicosanoid synthetic genes in a tissue specific manner as well as in
response to exogenously delivered antagonists into the airspace that specifically interfere with HxA3 or LTB4.
Collectively, this proposal seeks to elucidate key genes and the cells that express these key genes, which are
involved in orchestrating an infection-induced inflammatory pathway culminating in neutrophilic breach of
protective mucosal barriers. Achievement of these objectives holds tremendous potential towards developing
a novel class of anti-inflammatory therapeutics that can alleviate destructive lung inflammation at the mucosa.

Public health relevance
PROJECT NARRATIVE The objective of this proposal is to investigate the hypothesis that the bioactive lipid molecules (hepoxilin A3 and leukotriene B4) operate in tandem to direct neutrophils to breach the mucosal epithelial barrier during bacterial infection. The specific genes and the distinct cell types that express the specific genes responsible for synthesizing these lipid eicosanoid molecules will be identified as will their role in bacterial induced neutrophil trans-epithelial migration. Information gathered from this work will be instrumental in developing a novel therapeutic approach that effectively and exquisitely targets this inflammatory axis thereby alleviating destructive neutrophil driven tissue injury, which occurs in a wide array of lung inflammatory diseases, both infectious and otherwise.